Neuropeptide modulation in circadian neural circuits

PROJECT SUMMARY/ ABSTRACT
The biological circadian clock generates a series of time markers across the 24 h day, by which different
aspects of physiology and behavior (e.g., sleep, hormone release, temperature dynamics) may be aligned to
local time for optimal efficiency. The molecular mechanisms of the PER-dependent circadian clock (which is
a cell autonomous timekeeping system), and how the clock is set to local time, are both well-studied. Less is
known about how the molecular clock couples within pacemaker cells to cell physiology, and how the clock
uses intercellular communication to generate the multiple phase (markers) that are used by other clock cells,
and by non-clock bearing downstream cells and circuits. This laboratory studies circadian neurophysiology
in the model system Drosophila and the overall goal of this project is to understand how intercellular
communication among pacemakers is used to generate different phases of circadian output. The fly’s daily
rhythmic locomotor behavior is controlled by ~150 dedicated circadian pacemaker neurons whose internal
molecular clocks are highly synchronized. Neuropeptide signaling in circadian neural circuits of both insects
and mammals supports molecular synchrony: in Drosophila, the neuropeptide PDF (via the PDF receptor, a
G Protein-Coupled Receptor (GPCR)) serves this function. Importantly, PDF modulation supports normal
pacemaker circuitry in a second critical way: it inhibits the neuronal activity of identified pacemaker groups to
specific non-morning phases. Prior work generated a model whereby the cell-intrinsic molecular clock in all
pacemakers drives a common morning phase of enhanced neuronal activity. Yet in vivo, real-time
measurements of calcium dynamics reveal that different pacemaker groups in the Drosophila brain are not
synchronously active in the morning. Instead the different groups exhibit a stereotyped sequence of activity
periods, at different times of the day and night. Hence this diversity of active periods (circadian phases) is
generated primarily by cell interactions (especially neuropeptide modulation). Together these activity periods
represent the poly-phasic outputs of the pacemaker system. Now, to test and extend the model, this
research program will evaluate the hypothesis that two distinct forms of the PDF receptor may differentially
contribute to molecular clock synchrony versus to inhibition of pacemaker neuronal activity. Experiments are
also designed to identify the signaling pathways used by the receptor isoforms. Finally, work will extend
studies based on the recent identification of a membrane protein that interacts with PDF receptor: an
evolutionarily conserved magnesium ion transporter which co-regulates locomotor behavior along with PDF
receptor. Together, this work performed in Drosophila will also inform an understanding of circadian output
mechanisms in the mammalian brain, because the fundamental mechanisms of GPCR modulation are highly
conserved. More generally, it will be relevant to fundamental mechanisms of neural circuit modulation by
neuropeptides.

Public health relevance
PROJECT NARRATIVE Eukaryotic circadian clocks impact nearly every aspect of physiology and behavior. Their dysfunction contributes to cancer, as well as to mental illness (e.g., depression) and to metabolic diseases (e.g., diabetes). While we know a great deal about the details of molecular timekeeping within pacemaker cells, we know much less about how clock information is broadcast and interpreted. Circadian output generates a series of signals representing phase markers, according to which diverse downstream tissues and circuits bias their daily temporal activities. We will study the physiology of circadian output in Drosophila by focusing on the mechanisms, dynamics and regulation of neuropeptide modulation. The detailed mechanisms thus revealed will help define how clock information supports normal physiology and may also contribute to pathophysiology.